Effects of cannabis use on community-based alcohol treatment outcomes in adolescents

PROJECT SUMMARY/ABSTRACT
Most (60-90%) adolescents in treatment for alcohol use disorder (AUD) also have a co-occurring psychiatric
disorder (COD) other than substance use, and adolescents with AUD+CODs have worse treatment outcomes
compared to those with only AUD. Among adolescents seeking treatment for AUD+CODs, over 80% also use
cannabis. The adult AUD treatment literature demonstrates worse alcohol-related treatment outcomes for
individuals who used cannabis during AUD treatment, but similar information is missing regarding how
cannabis use might influence AUD+COD treatment processes. Consistent with NIAAA’s strategic plan to
improve treatment for AUD+CODs, this K23 proposal aims to fill a critical gap in understanding how cannabis
use affects AUD+COD treatment outcomes among adolescents in community-based treatment. Understanding
whether, for whom, in what contexts, and how cannabis use relates to treatment processes and AUD+COD
outcomes in real-world community-based treatment will inform viable and meaningful cannabis-related
intervention targets for adolescent AUD+COD treatment. This K23 will use mixed methods to inform how
cannabis use relates to AUD+COD treatment processes and outcomes. Participants will be recruited from
community-based intensive outpatient programs for AUD+CODs who also use cannabis. Aim 1a will use
qualitative interviews (N=25) to explore adolescents’ perspectives on their cannabis use in the context of
AUD+COD treatment. Aim 1b will use an open pilot ecological momentary assessment (EMA) study (N=5) to
solicit feedback and refine the Aim 2 protocol. Aim 2 will use 21 days of EMA during treatment plus longitudinal
follow-up surveys at 0-, 1-, 2-, and 3-months post-intensive outpatient treatment (N=90) to understand the
dynamics of how AUD+COD processes unfold when adolescents are using cannabis in their natural
environments. Results will shed light on how cannabis use affects AUD+COD treatment among adolescents
with AUD+CODs and identify productive treatment targets that prioritize adolescents’ lived experiences and
are relevant in community-based care. Results will also inform models of addressing polysubstance use in
treatment more broadly, which is prevalent in community-based care but largely neglected in clinical trials. This
K23 leverages the candidate’s expertise using EMA and multilevel modeling to study alcohol-cannabis co-use
while providing needed training in qualitative and mixed methods research, developmentally informed research
on adolescents in the context of community-based treatment, advanced structural equation modeling, and
professional development, to launch a successful NIAAA-funded clinical research career advancing adolescent
addiction science and community-based treatment. A mentorship team with unique and complementary areas
of expertise are committed to the candidate’s research and training.

Public health relevance
PROJECT NARRATIVE Most adolescents in treatment for alcohol use disorder and co-occurring disorders (AUD+CODs) use cannabis, yet little is known about the impact cannabis use has on AUD+COD treatment processes and outcomes. Consistent with NIAAA’s strategic plan to improve AUD+COD treatment, this K23 will use mixed methods to prioritize and understand adolescents’ experiences using cannabis in the context of community-based treatment for AUD+CODs, elucidate the dynamic effects of cannabis on treatment processes as they unfold when adolescents are using cannabis in their natural environments, and provide preliminary data on cannabis- related predictors of longer-term AUD+COD treatment outcomes. Results will inform productive and meaningful cannabis-related targets for AUD+COD treatment and inform models of addressing polysubstance use in treatment.